Mechanisms of Cell Cycle and Survival Regulation by Hedgehog Signaling

DESCRIPTION (provided by applicant): The Hedgehog (Hh) ligands (Shh, Ihh, and Dhh) signal through two membrane receptors (Ptc1 and Ptc2), the regulatory membrane protein Smoothened (SMO), and the Gli transcription factors. Ptc1 represses SMO in the absence of ligand while Hh binding results in Ptc1 inhibition and activation of SMO. Activation of Gli-dependent transcription by Hh-SMO is referred to as the canonical pathway; in contrast, Gli-independent functions of Hh proteins are classified as non-canonical. Gli activation requires the presence of the co-receptors Cdo/Boc and relocalization of SMO to a structure known as the primary cilium. Most human cancers are characterized by hyperactivation of the canonical Hh pathway due to upregulation of Hh ligands, loss-of-function of Ptc1, or gain-of-function of SMO. Remarkably, upregulation of Hh proteins is strictly associated with epithelial cancers. We identified novel signaling components downstream of SMO that lead to Gli activation and uncovered that SMO acts as a classical Gi-coupled receptor that stimulates signals involved in cell cycle regulation, survival, and migration. We have established novel paradigms revealing that Shh can activate small G proteins of the Rho family and lead to cytoskeletal rearrangements and changes in cell motility. We and others have found that Ptc1 induces apoptosis in the absence of Hhs via its C-terminal domain (CTD), and independently of SMO. Based on this evidence, we hypothesize that non-canonical signals, generated directly by Ptc1 or indirectly through SMO, are the main players in Hh-regulation of cell cycle progression, survival and migration. We will: 1) Characterize the mechanistic basis of non-canonical Hh signaling in proliferation, survival, and migration. We will first determine the potential implication of the primary cilium and the co- receptors Cdo/Boc in these responses. We will also investigate the mechanistic aspects of activation of small GTPases by SMO, and their involvement in cell migration. 2) Study the mechanism of regulation of cell cycle progression and apoptosis by Ptc1 independently of SMO/Gli activation. We will first determine whether membrane localization of Ptc1 CTD is necessary to drive cell death, and will identify the minimal fragment of the CTD required for apoptosis. Secondly, we will investigate the mechanism of Ptc1- induced Akt dephosphorylation, and the participation of the mitochondrial apoptotic pathway in Ptc1 CTD- induced apoptosis. Lastly, we will study the mechanisms that lead to cell cycle arrest by Ptc1. 3) Establish the contribution of Ptc1 and SMO signals for proliferation and survival of Hh overexpressing cancer cells. Peptides based on Ptc1 MCTD sequence and cyclopamine will be applied alone and in combination to Hh-overexpressing epithelial cancer cells and we will evaluate their effects on proliferation and survival. Overall, these studies will provide insights into the understanding of non-canonical Hedgehog pathway(s) and will set a mechanistic basis for development of new cancer therapeutics targeting Ptc1 functions.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal is aimed at dissecting the basic signaling mechanisms activated by the Hedgehog signaling pathway that are involved in regulation of cell cycle progression, survival and migration. We propose the novel hypothesis that the Hedgehog receptor Ptc1 regulates cell cycle progression and survival independently of the so-called "canonical" pathway, which involves Smoothened (SMO) and Gli-dependent transcription of target genes. Understanding the specific contributions of Ptc1 and SMO to signaling pathways implicated in growth, survival and cell cycle regulation in normal and cancer cells, will provide the basis for rationale development of therapeutic applications for human health. This proposal is aimed at dissecting the basic signaling mechanisms activated by the Hedgehog signaling pathway that are involved in regulation of cell cycle progression, survival and migration. We propose the novel hypothesis that the Hedgehog receptor Ptc1 regulates cell cycle progression and survival independently of the so-called "canonical" pathway, which involves Smoothened (SMO) and Gli-dependent transcription of target genes. Understanding the specific contributions of Ptc1 and SMO to signaling pathways implicated in growth, survival and cell cycle regulation in normal and cancer cells, will provide the basis for rationale development of therapeutic applications for human health. __SpecificAimsTextDelimiter__ Specific Aims The Hedgehog (Hh) signaling pathway has essential roles during embryonic development that are echoed in adult mammals by its involvement in cancer. The key components of the pathway include three Hh proteins (Sonic (Shh), Indian (Ihh) and Desert Hedgehog (Dhh)), two receptors termed Patched-1 and -2 (Ptc1 and Ptc2) and the regulatory protein Smoothened (SMO). Ptc1 represses SMO in the absence of ligand while Hh binding inhibits Ptc1 resulting in activation of SMO and the Gli transcription factors (1). Activation of Gli-dependent transcription by Hedgehog-SMO is referred to as the "canonical" pathway; in contrast, Gli-independent functions of Hedgehogs are classified as "non-canonical". Hh signaling has a critical role in a myriad of human cancers (2). Dysregulation of the pathway in cancer occurs most frequently via upregulation of Shh or Ihh, loss-of-function of Ptc1, and gain-of-function of SMO. These three types of changes lead to similar hyperactivation of the "canonical" Hh pathway and stimulation of Gli-dependent transcription. Upregulation of Hh proteins is strictly associated with GI tract and prostate cancers. However, Ptc1 or SMO mutations in those organs are not sufficient to drive malignant transformation (3). An attractive and yet unexplored possibility is that non-canonical Hh signaling pathways are required to sustain development of tumors of epithelial origin. In the last years, seminal cell biological and biochemical studies revealed a high degree of complexity in Hh signal transduction. For example, Gli activation is accomplished in an organelle known as the primary cilium and depend on co-receptors Cdo/Boc. Through different domains, SMO regulates pathway-specific components that lead to Gli activation and acts as a classical GPCR to stimulate signals involved in cell cycle regulation, survival, and migration (1). In addition, emerging evidence suggests that Ptc1 can signal in SMO-independent ways to regulate cell survival pathways directly. Based on published and unpublished observations that will be presented in this proposal, we hypothesize that non-canonical signals generated by SMO and Ptc1 regulate cell cycle progression, survival and migration in a Gli- independent manner. This represents a shift in paradigm in the field, since the Gli transcriptional response was believed to be required for all biological processes to Hh proteins. To test our overall hypothesis we propose to: Aim 1. Characterize the mechanistic basis of non-canonical Hedgehog signaling in proliferation, survival, and migration. We will first establish whether the mitogenic and survival functions of Shh via non- canonical pathways are initiated at the primary cilium by Ptc1 and the co-receptors Cdo/Boc. Second, we will investigate if there is also a SMO-independent component in Shh-induced proliferation and survival. Third, we will study whether the primary cilium and the co-receptors are involved in Shh-induced fibroblast migration. Lastly, as we have identified the involvement of the small GTPases Rac1 and RhoA in Hh signaling, we will study the mechanistic basis of this activation, including the potential role of Gi proteins and the PI3K pathway, as well as the identification of guanine nucleotide exchange factors (GEFs) and their involvement in Shh-induced migration. Aim 2. Study the mechanism of regulation of cell cycle progression and apoptosis by Ptc1 independently of SMO/Gli activation. Based on our preliminary data and recent literature that suggests that the C-terminal domain (CTD) of Ptc1 is required for Ptc1-induced apoptosis in the absence of Hh proteins (4), we propose to: 1) determine whether membrane localization of Ptc1 CTD is necessary to drive cell death, 2) to identify the minimal fragment of the CTD required for apoptosis, 3) to investigate the mechanism of Ptc1- induced Akt dephosphorylation, and 4) investigate the participation of the mitochondrial apoptotic pathway in Ptc1 CTD-induced apoptosis. In the second part, we will study the mechanisms that lead to cell cycle arrest by Ptc1. To this end, we will analyze the changes in expression of cyclins and CDK inhibitors as well as in the activities of cyclin/CDK complexes induced by Ptc1 independently of SMO/Gli activation. Aim 3. Establish the contribution of Ptc1 and SMO signals for proliferation and survival of Hh overexpressing cancer cells. To this end, we will compare the effect of interventions to manipulate Ptc1 and SMO signaling, alone or in combination, in human cancer cells lines characterized by Shh/Ihh upregulation, which depend on Hh for survival. To uncouple Ptc1 growth inhibitory signals from Hh regulation, we will introduce membrane-permeable peptides corresponding to the minimal CTD of Ptc1 with pro-apoptotic activity into the Hh-overexpressing cancer cells. We will dissect the apoptotic pathways implicated in Ptc1 CTD-induced cell death in cancer cells and the role of Akt dephosphorylation in this context. We propose that combined application of MCTD peptides and SMO inhibitors will result in synergistic cytotoxicity for the cancer cells. Overall, these studies will provide critical insights into the understanding of non-canonical Hedgehog pathway(s) and will set a mechanistic basis for development of new cancer therapeutics targeting Ptc1 functions.